IND-enabling development of MM-009, a reservoir-intravaginal ring for ultra-highrates of month-long lactic acid release to treat and prevent bacterial vaginosis

Summary
Millions of women in the U.S. suffer from bacterial vaginosis (BV), a vaginal condition characterized by
marked overgrowth of polymicrobial bacterial populations that greatly increases risks of preterm pregnancy and
other sexually transmitted infections. Antibiotics only provide transient relief from the foul-smelling discharge
caused by BV, and cannot treat recurrent BV or prevent BV from recurring (sometimes at a frequency up to
twice a month). There is no product on the market that can provide sustained protection against BV. In
exploring potential non-antibiotics-based interventions for BV, we became motivated by the highly reproducible
clinical observation that women with Lactobacillus crispatus-dominant vaginal microbiome are highly resistant
to BV. “Healthy” lactobacilli (LB), in particular L. crispatus, secretes lactic acid (LA) that acts as a broad-
spectrum microbicide that suppresses various BV species, with much greater activity than acetic acid. We
recently determined the rate at which healthy lactobacilli continuously produce LA. Hence, for the first time, we
know the rate at which LA should be supplied to the vagina to treat and prevent BV. These insights have
guided our development of “MM-009”, a LA-releasing intravaginal ring (LA-IVR) that can provide release of
LA over at least 30 days, at rates designed to treat and prevent BV while not suppressing healthy LB. Our first-
generation MM-009 lowered the vaginal pH in macaques substantially without causing any toxicity, as well as
release enough lactic acid to promote a LB-dominated microbiome for over a week. We further tested this MM-
009 in a sheep vaginal model and observed similar results validating high rates of LA release and lack of
toxicity. Noting the lack of toxicity in our current formulation and the potential to further increase rates of LA
release, we have now developed a second-generation MM-009 as a proprietary reservoir-IVR system that
allows us to precisely tune LA release rates with near zero-order release kinetics, achieving LA release at rates
orders of magnitude greater than what had been previously reported. Building off of these promising results,
our goal in the first portion of this Phase 2 proposal is to select a lead candidate LA-IVR in the well-established
sheep vaginal model for safety and pharmacokinetics (Aim 1). The latter part of this Phase 2 proposal, guided
by the pre-IND feedback from the FDA, will focus on the developing cGMP production processes for MM-009
that will support production of MM-009 for IND-enabling and Phase 1-2 studies (Aim 2). Lastly, we will execute
key IND-enabling studies, including GLP sheep toxicology, rabbit vaginal irritation, and biocompatibility studies
(Aim 3). The simplicity of our MM-009 LA-IVR design ensures both ease of production and likely very low
manufacturing costs of the eventual MM-009 product, which in turn should maximize potential public health
impact and commercial viability of the product both in the U.S. and in low and middle income countries
worldwide.

Public health relevance
Narrative Bacterial vaginosis (BV) is a frequently recurring vaginal condition that greatly increases risks of sexually transmitted infections and adverse pregnancy outcomes. Here, we will advance an intravaginal ring that can steadily deliver large amounts of lactic acid, a potent inactivator of various BV microbes. Successful completion of this project will enable us to advance into clinical study a potentially safe, affordable and effective method for protecting millions of women from BV.